Clinical evaluation of a novel AKT/PDK1 inhibitor, PHT-427, for the treatment of multi-field actinitc keratoses

ABSTRACT
Actinic keratosis (AK) is the premalignant dysplastic proliferation of keratinocytes on sun-exposed skin affecting
more than 58 million individuals in the US, that can progress in up to 10% of cases to cutaneous squamous cell
carcinoma (cSCC), with 1.8 million cases diagnosed annually and 15,000 dying from the disease. Because of
the risk of progression AK should not be left untreated. For isolated lesions surgery, cryotherapy and
photodynamic therapy are used, having to be repeated as additional lesions inevitably occur. Field ablation for
multiple lesions uses topical creams containing 5FU or imiquimod but they have significant toxicity and lesion
clearance rates are low and not much greater than placebo. The leaves a large unmet medical need for less
toxic and more efficacious treatments for AK. Sun-exposed skin has a high incidence of UV DNA damage leading
to mutations in AK and cSCC that are remarkably similar. While tumor suppressor loss-of-function mutations are
most common they are difficult to treat. Oncogenic PI-3-kinase is mutated in half of AK and cSCC making it an
attractive target. PHusis Therapeutics has developed PHT-427 as a lipophilic, dual inhibitor of AKT1/2/3 and
PDPK1 downstream PI-3-kinase signaling that specifically blocks membrane binding of their pleckstrin homology
(PH) domains. PHT-427 applied topically to mice with UV-B induced AK significantly decreases the size and
number of AK lesions by readily permeating the stratum corneum to give high skin concentrations, but with low
transdermal absorption into the blood stream and minimal toxicity in mice, or rabbit skin as a model for human
skin. The hypothesis being tested is that the dual AKT/PDK1 inhibitor PHT-427 applied topically will be a
convenient, effective and low toxicity treatment of human AK and cSCC caused by activated PI-3-kinase
signaling. In this Direct to Phase II SBIR application, PHusis Therapeutics proposes to perform a Phase IA
clinical trial to study safety and PK of topical PHT-427 as a treatment for AK in human subjects.

Public health relevance
NARRATIVE AK currently affects more than 58 million individuals in the USA and is a premalignant form of cutaneous squamous cell carcinoma. Recommended therapies for isolated AK lesions are surgery, cryotherapy and photodynamic therapy. PHusis Therapeutics' goal is to test PHT-427 as a topical agent in a Phase IA clinical trial in patients with AK.